Administrative Core

The Administrative Core will provide support to facilitate interactions among all ofthe project leaders and their scientific teams, and efficient and productive interactions between the U19 project teams and the advisory committee. The Administrative Core will serve the coordinating functions for the proposed U19, and will ensure transparency and cost-effectiveness in all aspects of our operations. To leverage available workflow and infrastructure, the administrative core will operate within the administrative framework of the Sandler Asthma Basic Research Center.

Public health relevance
This core will allow for the projects to meet their aims by facilitating interactions among all of the project leaders and their scientific teams, and efficient and productive interactions betw/een the U19 project teams and the advisory committee. This will allow for transparency and cost-effectiveness, allowing the entire project to serve public interests in the most efficient way.